A novel framework for nanomedicine development

Project Summary
Nanomedicine is a research field centered around applying materials in the nanoscale size range (i.e.
nanoparticles) as therapeutics and diagnostics. However, a major challenge is the safe, efficient, and effective
delivery of nanoparticles to biological systems, such as cells, tissues, and organs. In this project, we will introduce
and explore a novel framework for nanomedicine development with the ultimate goal of efficiently delivering non-
viral nanoparticles to cells and tissues for safe and effective applications. Our proposed research program has
three main strands: (i) we will develop novel nanoparticles for the safe, efficient, and effective delivery of small
molecules and nucleic acid payloads to skeletal muscle cells; (ii) we will develop novel methods for super-
resolution bioimaging to study the mechanisms and kinetics of nanoparticle spatiotemporal transport in biological
systems; (iii) we will quantify safety, efficiency, and effectiveness of nanoparticle in vivo delivery. Using this novel
framework, our long-term scientific goal is to create a major breakthrough in nanomedicine by developing safer,
more efficient, and more effective nanoparticles for the non-viral delivery of small molecule-based drugs and
nucleic acid payloads to enable therapeutic applications in skeletal muscle disorders.

Public health relevance
Project Narrative The long-term goal of the proposed research program is to establish a novel framework for nanomedicine development, which will enable safer and more effective applications of nanotechnology in medicine. The proposed research will impact the therapeutic uses of nanomedicine across multiple areas of medicine in line with the mission of the National Institute of General Medical Sciences (NIGMS).